The Role of Diet in COPD Rehospitalization

PROJECT SUMMARY
Chronic obstructive pulmonary disease (COPD) is a leading cause of death in the United States, with a
disproportionately high prevalence among individuals with low socioeconomic status (SES). Hospitalizations
for acute exacerbations of COPD (AECOPD) are common and come with a high risk of rehospitalization.
Among individuals hospitalized with COPD, 20% are rehospitalized within 30 days, and low SES is associated
with increased risk of rehospitalization. Multiple causal mechanisms have been proposed for the association
between low SES and COPD morbidity. Specifically, adverse dietary patterns and food insecurity can affect
COPD morbidity and may be acutely worse following hospital discharge. Previous interventions aimed at
preventing rehospitalization through COPD-specific treatments have had mixed results, and the American
Thoracic Society (ATS) has recommended programs expand beyond solely focusing on guideline-
recommended care for COPD to include issues related to social determinants of health. To investigate diet as
a potentially modifiable factor linking SES to COPD morbidity, we propose to study the association of diet
quality and food insecurity with rehospitalization risk in 120 individuals hospitalized for AECOPD. We will
assess diet quality after hospital discharge in terms of general quality, using the Alternative Healthy Eating
Index-2010, as well as specific patterns associated with COPD morbidity, such as low omega-3 fatty acid
intake. We will additionally examine food insecurity, a household’s economic and social conditions resulting in
limited or uncertain access to adequate food, which is related to SES and may influence diet quality and
rehospitalization risk. Furthermore, we will conduct semi-structured interviews with a subset of participants to
identify contributors to diet quality and food insecurity during the transition from hospital to home. Finally, we
will conduct a randomized trial of prepared meal delivery following hospital discharge among 36 individuals
admitted for AECOPD to determine if such interventions can improve diet quality, affect biomarkers associated
with COPD morbidity, and potentially decrease rehospitalization rates. Completion of the proposed aims will
elucidate the role of dietary factors on rehospitalization risk in COPD and inform the design of a larger
randomized controlled trial of diet intervention following hospitalization for AECOPD. We will leverage
infrastructure created for an ongoing cohort study of individuals hospitalized for AECOPD at the Johns Hopkins
Bayview Medical Center as well as the Johns Hopkins COPD Precision Medicine Center of Excellence. My
ultimate career goal is to be an independent clinical researcher focusing on interventions that address health
disparities in COPD. My career development plan includes expert mentorship, formal coursework, and hands-
on experience to develop new skills in cohort and clinical trials design, nutrition research, and qualitative
research methods.

Public health relevance
PROJECT NARRATIVE Chronic obstructive pulmonary disease (COPD) is a leading cause of death and hospital admission in the United States, and patients hospitalized with COPD often return to the hospital within a month of discharge. Programs that have tried to prevent repeat hospitalizations for COPD have largely not been successful and have primarily focused on adherence to inhaler treatments. Evidence is emerging that a healthy diet may play an important role in preventing COPD flares, thus we propose to study the effects of diet quality and access to healthy foods among patients recently discharged from the hospital for COPD, with the aim of reducing hospital readmission.